FGF and hyaluronan-mediated alterations in epithelial-mesenchymal transition and metabolism of RPE cells in Sorsby Fundus Dystrophy.

PROJECT SUMMARY
Sorsby fundus dystrophy (SFD) is a dominantly inherited, degenerative disease of the macula that is
characterized by bilateral loss of central vision as a consequence of RPE dystrophy and choroidal
neovascularization (CNV). Specific mutations in the TIMP-3 gene involving exon 5 or the intron4-exon5
boundary have been shown to be causative. The age-related macular degeneration (AMD) consortium has
identified rare coding variants in the TIMP3 gene when analyzing 16,144 patients and 17,832 controls. The
clinical and histopathological similarities between AMD and SFD and the identification of variants in the
matrix metalloproteinase pathway in AMD suggest that similar downstream effectors might be in play in both
conditions. A better understanding of the pathophysiological mechanisms contributing to the CNV in SFD will
provide information that could be potentially useful in AMD. In comparative studies using TIMP-3 deficient
mice, S179CTIMP-3 transgenic mice and in vitro culture experiments we have determined that RPE cells
expressing mutant TIMP3 undergo epithelial-mesenchymal transformation (EMT) and have altered
metabolism. These changes are correlated with increased bFGF and hyaluronan deposition. Based on these
results, we hypothesize that under physiological conditions, TIMP3 is required to control and localize matrix
degradation in the RPE/choroid which keeps the RPE in an epithelial state and allows for normal metabolic
activity. Loss of TIMP3 function in this regard leads to EMT and altered metabolism which could have
significant effects on RPE and retinal health.

Public health relevance
NARRATIVE Sorsby fundus dystrophy is a rare inherited disease caused by mutations in Tissue Inhibitor of Metalloptroteinase-3, that leads to loss of vision and has striking similarities to age-related macular degeneration (AMD). The exact molecular and pathological mechanism(s) that lead to vision loss in either of these conditions has not been identified. Given that mutations in TIMP3 always cause SFD (100% penetrance), knowledge gained from examining the abnormalities in the RPE and retina due to these variations is critical to understanding the pathogenesis of retina/RPE/choroid dysfunction in macular dystrophies. The knowledge gained from these studies will not only contribute to our understanding of fundamental principles of retinal physiology and pathology in SFD, but may also lead to the development of new therapeutic approaches for SFD as well as AMD and other macular degenerative diseases.